Community College Consortium for Health and Safety at DOE Sites

? DESCRIPTION (provided by applicant): The Partnership for Environmental Technology Education (PETE) submits this application on behalf of the Community College for Health and Safety Training (CCCHST) serving Department of Energy (DOE) environmental restoration and waste management sites at: Oak Ridge Operations, TN; Portsmouth Site, OH; Paducah Gaseous Diffusion Site, KY; Savannah River Site, SC; Pantex, TX. The intent of CCCHST-DOE is to provide convenient, consistent, memorable, and cost-effective 29 CFR 1910.120 worker training to DOE contractors and subcontractors. Workers gain the knowledge and skills to protect themselves and their communities from exposure to hazardous materials during hazardous waste operations, facility decommissioning and decontamination, hazardous materials transportation, environmental restoration of contaminated facilities or chemical emergency response. Over the five-year award, CCCHST members including the University of Tennessee, Amarillo College and Greenville Technical College will train a minimum 12,500, workers, technicians and supervisors, through 75,000 contact hours of training, to protect themselves, their facilities, and their communities from exposure to hazardous materials encountered during hazardous waste site clean-up, in the transportation of hazardous materials, and in the response to releases of hazardous materials. Each year, 2,500 workers will successfully complete 250 courses for a total 15,000 contact hours of training. Annually, an average 75 courses will be delivered online. PETE will provide hazardous materials curriculum, developed by HMTRI and adapted and maintained by PETE for student use. PETE will provide students online access to curriculum for 24 hours of the 40-hour HazWoper and 8-hour Refreshers. PETE will provide centralized record keeping and quality control for the consortium, submitting to the NIEHS data management system the number of students trained at CCCHST-DOE sites and their demographic data, registering curricula with the NIEHS Clearinghouse, providing technical assistance, conducting site audits, reviewing student evaluations, acting upon the guidance of the advisory committee, and mediating the delivery of training with other NIEHS-supported consortia.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Department of Energy and predecessor agencies have been involved in the research, production and testing of nuclear weapons since the 1940s. During that time, numerous facilities, both government and privately-owned, were constructed or leased across the country to support the effort, generating large quantities of radioactive and hazardous materials that resulted in the contamination of many of the facilities and surrounding areas. In 1994, to protect the staff and workers doing DOE cleanup and waste management work, legislation was enacted to allow the Department of Energy to fund NIEHS to develop Worker Training programs that would assure workers, other facility personnel, and community responders the knowledge and skills to protect themselves and their communities from hazardous conditions in the workplace. National PETE and its Community College Consortium for Health and Safety Training (CCCHST) has been continuously supported by NIEHS since 1995 to provide quality training that is efficient, consistent, flexible, and cost-effective for th multiple tiers of contractors at DOE sites.